First Responder Safety and Well-being Amid the Hurricane Helene Response

PROJECT SUMMARY
Emergency first responders are at significant risk for injury, illness, and death during disaster response and
recovery operations, particularly with the growing frequency and severity of disaster events such as Hurricane
Helene that impacted Western North Carolina in the Fall of 2024. This disaster continues to draw first
responders from different areas of the state and regionally, presenting a unique opportunity to assess
environmental hazards’ impact on first responders. The National Institute for Environmental Health Sciences’
(NIEHS) Disaster Research Response Program’s (DR2) crosscutting strategy to address the consequences of
disasters notes that critical opportunities like this are often missed to better understand physical and mental
health impacts of these events. It is clear that we must determine if first responders are able to recognize and
be fully prepared for the unique hazards they may encounter. An important gap exists in our understanding of
current and emerging safety, health, and psychosocial hazards placing first responders at risk, particularly as
they occur in areas where the complexity of response is increased (e.g., landslide risk). A critical need exists to
study first responders who have recently participated in response and recovery operations to best determine
hazards and how personal, organizational, and other factors of the job place them at risk. The objective of this
project is to better identify the range of environmental hazards encountered by first responders during
response and recovery operations, and how these hazards impact perception of risk, particularly psychosocial
hazards, and then identify key areas to improve training for responder preparedness. The proposed study is
innovative due to: (1) the use of the National Institute for Occupational Safety and Health's Burden, Needs, and
Impact method, a well-validated tool that aids identification of environmental impacts and research priorities;
(2) a Total Worker Health® (TWH) approach to assess environmental factors impacting responder well-being;
and (3) the extraordinary opportunity to aid first responders per the time sensitive nature of the event. In Aim 1,
we will conduct one-on-one interviews and focus groups with a variety of first responders (e.g., firefighters,
EMS, law enforcement) to identify the current and emerging personal hazards encountered in the response
which increase their risk of injury, illness, and mental distress. In Aim2, we will apply the TWH framework to
inform responder preparedness through identification of broader workplace and organizational factors
impacting responder safety, health, and well-being. In Aim 3, we utilize a participatory approach working with
first responders to develop training recommendations to better protect their safety, health, and well-being. The
expected outputs and outcomes of this project will inform the NIEHS DR2 goal of “identifying both immediate
and long-term potential physical and mental health effects of disaster events” utilizing insights obtained directly
from first responders actively engaged in the Hurricane Helene response.

Public health relevance
PROJECT NARRATIVE Emergency first responders are highly skilled experts in emergency response and recovery operations, yet disaster events such as Hurricane Helene that devastated western North Carolina have increased in magnitude and scope, placing responders at increased risk of injury, illness, or death. As current and emerging hazards continue to emerge from these unique disasters, in conjunction with responders assisting from different geographic locations, it is likely they may not be fully prepared for the event, increasing risk for adverse safety, health, and well-being impacts (e.g., depression, PTSD). Therefore, we work directly with first responders to assess the hazards and risk factors encountered during the Hurricane Helene response and to identify training measures needed to better prepare and protect first responders.